Microvascular endothelial lipid metabolism as a target for age-related vascular cognitive impairment

PROJECT SUMMARY/ABSTRACT
Lipids constitute ~50% of the brain’s dry weight, yet very little is known about how brain lipid metabolism
is regulated in both physiological and pathological states. Lipid droplets (LDs) are lipid-storing organelles that
play a significant role in regulating cellular lipid metabolism. Dysregulated lipid homeostasis, resulting in
excessive accumulation of LDs in brain cells, has been implicated in neuroinflammation associated with aging
and other neurodegenerative diseases. While most studies have focused on lipotoxicity in glial cells, our
single-cell RNA-sequencing (scRNA-seq) analysis reveals that brain endothelial cells are equally vulnerable to
age-related LD accumulation. Endothelial cells accumulating LDs in the aged brain displayed a
transcriptomic signature associated with reduced LD turnover, increased neuroinflammation, and impaired
blood-brain barrier (BBB) function. However, the mechanisms by which age-related lipid dysregulation in brain
vascular cells, specifically endothelial cells, contribute to cognitive impairment remain poorly understood. In
this novel pilot study, we build on our exciting preliminary data and propose that decreased lipid turnover
induces microvascular endothelial dysfunction, which impairs cerebral blood flow responses,
promotes BBB disruption, and triggers neuroinflammation, ultimately leading to cognitive decline in aging.
To test this hypothesis, we will knock down the critical triglyceride hydrolytic enzyme, adipose triglyceride
lipase (ATGL), specifically in brain endothelial cells using the recently developed AAV serotype BI30. We will
utilize this model to evaluate how LD accumulation in endothelial cells drives microvascular aging and
cognitive impairment. In Aim 1, we will assess the effects of LD accumulation on endothelial structure and
function. In Aim 2, we will evaluate how endothelial LD accumulation impacts endothelial bioenergetics and
cognitive function in aging. The successful completion of these studies will pave the way for novel
therapeutic strategies targeting endothelial lipid metabolism to delay or prevent cognitive decline
associated with aging and neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE Vascular contributions to cognitive impairment and dementia (VCID) are a significant public health concern, representing one of the leading causes of cognitive decline in older adults. Endothelial dysfunction plays a major role in VCID, but the underlying mechanisms remain poorly understood. In this project, we will investigate the role of dysregulated lipid metabolism in brain endothelial cells as a potential target for treating age-related cognitive decline.